EVALUATION OF TECHNIQUES FOR THE ANALYSIS OF LIPOPROTEINS AND APOLIPOPROTEINS

Because of the high prevalence of dyslipoproteinemias and their association with atherosclerotic cardiovascular disease (CVD), measurements of plasma lipids, lipoproteins, and apolipoproteins are often required for diagnosis and follow-up of patients. We will establish techniques for the detection and quantitative measurement of diagnostically important lipoproteins, [e.g., Lp (a)] and apolipoproteins (e.g., apo E).